SAFETY/EFFICICY OF ZDV IN THERAPY OF PATIENTS WITH EARLY ARC

The purpose of this study is to determine the natural history of early symptomatic HIV infection in subjects receiving ZDV therapy. The disease free interval will be monitored and long-term efficacy and toxicity will also be evaluated.